NCI R50 Clinician Scientist Award

ABSTRACT/SUMMARY
NCI clinical trials networks are essential to strengthen the cancer care of the nation by expediting the discovery
of novel cancer treatments and therapeutic strategies. Central to this effort are the clinician scientists who
development, implement, manage, and provide oversight to these individual trials and trial networks. While
essential, these clinicians are frequently tasked with significant clinical, administrative, and teaching
responsibilities that may inhibit substantiative contribution to NCI-sponsored clinical trial activity. The R50
Research Specialist /Clinician Scientist Award is designed to protect time and allow the clinician scientist to
significantly contribute to NCI-sponsored clinical trials and NCI clinical trials networks through leadership in the
development of national clinical trials, implementation of NCI clinical trials in their institutions, and national
service to the NCI clinical trials networks.
Dr. Brian Jonas, MD, PhD, is a leukemia specialist and an Associate Professor within the Department of
Hematology/Oncology at UC Davis Comprehensive Cancer Center (UCDCCC). As an active and highly
dedicated clinical scientist and trialist at UC Davis, he has established himself as a leader in opening clinical
trials for the treatment of AML, MDS, acute lymphoblastic leukemia (ALL) and other hematologic malignancies.
Moreover, he has received the coveted “Top Accrurer” Award within the cancer clinical trials unit. His clinical
research is complemented by his translational studies involving AML biomarkers, chemosensitivity and
therapeutic targeting of leukemia stem cells. As an asset to UCDCCC, he has served as PI on several clinical
trials and as a leader in clinical trials management. This includes chairing the UCDCCC Hematologic
Malignancies Disease Team Committee and the UCDCCC Data and Safety Monitoring Committee.
In addition to his contributions at UC Davis, Dr. Jonas has contributed to multidisciplinary clinical and translational
teams such as the Leukemia Committee and Working Group for the Southwest Oncology Group (SWOG), and
the Calif ornia Cancer Consortium to shape and inf orm clinical trial portf olios at the UCDCCC, the National Clinical
Trials Network (NCTN) and the Experimental Therapeutics Clinical Trials Network (ET-CTN). This includes his
service as national chair of two ECTCN trials developed through the CTEP Project Team mechanism and the
SWOG champion for an ECOG-ACRIN AML trial in development through the NCTN. He is also an active
participant in the UM1 Consortium, the California Cancer Consortium (CCC), and a member of the CCC Heme
Working Group. Overall, Dr. Jonas is a well-qualified clinician scientist candidate for the NCI R50 Research
Specialist Award and has demonstrated prior and continuing leadership in the development of national clinical
trials, implementation of NCI-sponsored clinical trials at UCD, and service to NCI clinical trial networks through
participation in our CCC. The R50 award will facilitate continued growth of his research program and
advancement of his institutional and national leadership.

Public health relevance
PROJECT NARRATIVE NCI-sponsored clinical trials are essential to improve the prevention, detection, and treatment of cancer. While highly trained and productive clinical trialists are needed to develop, initiate, and manage these trials, competing responsibilities often limit their contribution to these efforts. Support fromthe R50 will allow Dr. Jonas to continue his development as a leader in NCI-sponsored clinical trial activities and ultimately improve the lives of patients with acute leukemia and myelodysplastic syndromes (MDS).